Administrative Core

PROJECT SUMMARY
The purpose of the Program is to bring together a team of investigators to focus on the pathobiology of two
important disease states, Chronic Lung Allograft Dysfunction and idiopathic pulmonary fibrosis using both
state-of-the-art animal modeling and human samples. The goals of this Program are to improve our
understanding of the mechanisms that contribute to disease progression and identity novel therapeutic targets
to combat lung fibrosis whether it occurs in the airway or in the interstitium of the lung. The Program brings
together a team of scientists and physician scientists with complementary skills to work as a unit on these
important problems. In order to coordinate these efforts, we propose an Administrative Core to facilitate
interactions and adherence to NIH regulations regarding management of PO1 proposals. We propose the
following Specific Aims:
 Coordinate and facilitate administration of the Program between Project Leaders and Core Leaders.
 Coordinate and facilitate administration of the Program between investigators, internal and external
advisors and an enrichment program organized to maximize scientific productivity.